Neurobiological Underpinnings of Pain-Related Symptoms in Early Onset Psychosis

ABSTRACT
Patients with early onset psychosis (EOP) demonstrate poorer long-term prognosis and higher rates of residual
symptoms and disability relative to cases of adult-onset psychosis. Children with EOP often report moderate to
severe pain, which is not explained by discoverable causes or associated with objective findings (e.g.,
inflammation, swelling, or redness). Pain reported by EOP patients introduces significant functional impairment
for the child and hinders basic activities such as self-care. While abnormal pain perception and processing in
adults with psychosis has been documented, the clinical, behavioral, and neurobiological characteristics
associated with pain in EOP have rarely been studied. A characterization of pain in EOP patients will provide a
developmental window into earlier stages of this phenomenon and course of the illness as well as during a period
of active CNS maturation. The objective of this proposal is two-fold. Objective 1 is to evaluate male and female
EOP patients (N=30, 13-18 years of age) with clinical instruments informing on pain severity and quality,
somatization, central sensitization and mental health. A parallel set of clinical questionnaires will be administered
in age-gender matched healthy controls (HCs, N=30) and two matched clinical comparator conditions; complex
regional pain syndrome (CRPS, N=30) and attention-deficit/hyperactivity disorder (ADHD, N=30). Objective 2
is to identify behavioral and neural correlates of dysregulated pain perception and processing in EOP patients
(N=30) and HCs (N=30). For Objective 2, we propose to phenotype participants by combining the Structured
Clinical Interview for DSM-5 (SCID-V) Axis I diagnoses, with additional modules from the Kiddie Schedule for
Affective Disorders and Schizophrenia (KSAD), Brief Psychiatric Rating Scale (BPRS) and Positive and Negative
Symptom Scale (PANSS), alongside assessment of pain sensitivity (quantitative sensory testing), cognition, and
CNS function and structure using magnetic resonance imaging (MRI) based methods. We will also explore the
utility of functional near infrared spectroscopy (fNIRS) in EOP. fNIRS is a non-invasive, cost-effective, and mobile
neuroimaging method that has not been widely used in EOP. Our overarching hypothesis is that EOP patients
presenting with severe psychiatric symptoms will present with a robust pain phenotype, while the function of
central nervous system (CNS) structures implicated in top-down regulation of pain and sensorimotor processing
are aberrant. To test our hypothesis, we propose the following Specific Aims. Aim 1: Characterize the
presentation of pain in children with EOP. Aim 2: Define behavioral and neural correlates of dysregulated pain
perception and processing in EOP. Exploratory Aim 3: Define resting-state CNS functional properties in EOP
using fNIRS. To study dysregulated pain perception and processing in patients with EOP, our Boston Children’s
Hospital based team will leverage our clinical and research expertise in pediatric pain and psychiatry, pain
neurobiology, neuroimaging, biostatistics, among other domains.

Public health relevance
Neurobiological Underpinnings of Pain-Related Symptoms in Early Onset Psychosis NARRATIVE Aberrant pain perception and processing as well as persistent pain can introduce functional impairment and cause mental anguish in patients diagnosed with early onset psychosis (EOP), yet this aspect of the condition has very rarely been studied. We hypothesize that EOP patients presenting with severe psychiatric symptoms will present with a robust pain phenotype, while the function of central nervous system (CNS) structures implicated in top-down regulation of pain and sensorimotor processing are aberrant. The proposed work will utilize functional and structural neuroimaging in conjunction with clinical and behavioral methods in order to determine factors that underlie abnormal pain perception and processing in EOP.